Analysis of Serum Progesterone and Estradiol

The purpose of this study is to measure estradiol and progesterone serum concentration in CD-1 mice administered various dose levels of PFOA (Perfluorooctanoic Acid)